The Study of the Circadian Rhythm in p53 Signaling

DESCRIPTION (provided by applicant): In mammals, the circadian clock controls most cellular processes in vivo including cell proliferation. Disruption of circadian rhythms leads to increased tumor development in animal models as well as in humans. The mammalian circadian clock is operated by the feedback loops of the circadian genes and is composed of a central clock in hypothalamus, the circadian input and output pathways, and peripheral clocks in all tissues studied. We have reported previously that the expression of c-myc and p53 follows a circadian rhythm in vivo and loss of function in the circadian genes, Period1 and 2, leads to neoplastic growth and deregulated DNA damage response in mice. Recently, we discovered that the central clock can entrain cell cycle and peripheral clocks by controlling the circadian rhythmicity of the sympathetic nervous system that simultaneously activates peripheral clock, cell cycle clock and p53 via activating Period1 and 2, Ap1-myc and ATM-p53 signaling. Disruption of circadian behavioral rhythm desynchronizes the central and peripheral clocks and uncouples p53 and Myc signaling resulting in oncogenic Myc activation, uncontrolled cell proliferation, and increased tumor development. In this application, we propose to study the mechanism and biological significance of circadian control of ATM-p53 signaling using a combination of molecular, cellular and genetic approaches. Specifically, we will focus on defining 1) the direct and indirect role of the peripheral clock in controlling ATM activation in response to sympathetic signaling; 2) the role of the sympathetic signaling as a circadian time cue to activate peripheral clock and ATM via controlling interacting signaling pathways; and 3) the mechanism of deregulation of ATM-p53 signaling by disruption of circadian behavioral rhythm and the possibility of reducing radiation- induced host tissue damage by circadian gating ATM-p53 activation at a specific time of a day.

Public health relevance
PUBLIC HEALTH RELEVANCE: In industrialized societies, changes in lifestyles lead to frequent disruption of endogenous circadian rhythm in about 50% of the human population, which contributes to increased cancer development world-wide. We plan to investigate how the clock controls the expression of the tumor suppressor p53, which is deregulated or mutated in most of types of human cancers. Our studies will lead to a better understanding of the mechanism of cancer and to the development of novel therapeutic strategies for cancer prevention and treatment. In industrialized societies, changes in lifestyles lead to frequent disruption of endogenous circadian rhythm in about 50% of the human population, which contributes to increased cancer development world-wide. We plan to investigate how the clock controls the expression of the tumor suppressor p53, which is deregulated or mutated in most of types of human cancers. Our studies will lead to a better understanding of the mechanism of cancer and to the development of novel therapeutic strategies for cancer prevention and treatment. __SpecificAimsTextDelimiter__ A. Specific Aims The long-term goal of our research is to understand mechanisms of oncogenesis and to develop more efficient approaches for cancer prevention and treatment. In this application, we propose to study the mechanism of circadian control of ATM-p53 signaling. Most physiological processes in mammals display circadian rhythms, which are generated by an endogenous circadian clock that is operated by circadian genes and composed of a central clock in the brain, the circadian input and output pathways, and the subordinate clocks in all peripheral tissues studied. It has been known since the 1940s that mitosis follows a circadian rhythm in rapid turnover human tissues, which is often disrupted in advanced stage tumors. Studies since the 1960s have revealed that disruption of circadian rhythm accelerates tumor development and progression in rodents as well as in humans. Recent studies have shown that mice lacking the circadian genes Period1 and 2 (Per) or Cryptochrome1 and 2 (Cry) are deficient in cell cycle regulation in peripheral tissues. In particular, we have found that Per2-mutant mice are cancer prone. However, it remains unclear whether tumor suppression is a non-clock function of Per2, how circadian rhythm in cell proliferation is generated in vivo, and why disruption of circadian rhythm leads to tumorigenesis. Recently, we found that cell proliferation rhythm is generated by central clock-paced extracellular mitogenic signals that drive peripheral clock-controlled expression of cell cycle and tumor suppressor genes. The effects of the central clock are mediated by the sympathetic nervous system via Ap1 and ATM, leading to simultaneous activation of c-Myc and p53. Disruption of circadian rhythm desynchronizes the central clock-SNS-peripheral clock axis, abolishes peripheral clock function, and uncouples p53 and c-Myc signaling, resulting in increased incidence of hormone-related tumors in mice. Our studies identify a previously unknown molecular pathway that links disruption of circadian rhythm to tumorigenesis. p53 is well known to respond to diverse cell signaling pathways and regulate genes controlling cell proliferation, apoptosis, senescence, metabolism, and genomic stability. Mutation or deregulation of p53 is the most common malignant lesion in human cancers. The importance of p53 in tumor suppression has stimulated intensive studies of this gene in the past few decades, leading to the identification of a variety of post-translational modification mechanisms controlling p53 expression in cell culture experiments. However, how p53 expression is regulated in vivo under various physiological conditions is still not clear. Further study of the mechanism of circadian control of p53 signaling will lead to a better understanding of the mechanism of cancer and to the development of novel therapeutic strategies for cancer treatment. We hypothesize that (1) the circadian clock generates the circadian rhythm in p53 expression through controlling ATM activation, (2) the circadian rhythm in ATM activation is controlled by coupled activities of the central and peripheral clocks in vivo, and (3) disruption of the coordination of the central and peripheral clocks abolishes the circadian rhythm of ATM activation, leading to the inactivation of p53 in the absence of p53 mutation. The specific aims for testing our hypotheses are: 1) To define the role of the peripheral clock in ATM activation by directly controlling ATM nuclear localization and activation in response to sympathetic signaling and/or by controlling the expression ¿-Arrestin2. 2) To define the role of sympathetic signaling in controlling peripheral clock and ATM activation via rhythmically activating interacting signaling pathways in peripheral tissues in vivo. 3) To define the mechanism of suppressing ATM-p53 signaling by disruption of circadian behavioral rhythm and to study the possibility of reducing radiation-induced host tissue damage by circadian gating the SNS-induced ATM-p53 activation at the time of radiation treatment.